Exposing synthetic lethal vulnerabilities in EBV-positive AIDS-NHL through novel replication dependency factors

PROJECT SUMMARY
Virus-associated lymphomas cause significant morbidity and mortality in HIV-infected individuals – indeed, the
oral pathogen Epstein-Barr virus (EBV) contributes to up to 90% of diffuse large B-cell lymphomas (DLBCL) and
40% of Burkitt lymphomas (BL). Although combined antiretroviral therapy (cART) and chemotherapy have
improved outcomes for AIDS lymphomas, challenges remain particularly with virus-associated AIDS lymphomas,
prompting efforts to better understand virus-associated factors and pathways. In particular, EBV-driven cellular
genome replication which is essential to lymphoma proliferation remains underexplored.
Upon infection of B cells, EBV drives host DNA replication which is essential for establishment of viral latency
as well as proliferation of cancer cells. However, such viral oncoprotein-driven DNA replication is plagued with
physical and functional obstacles, resulting in replication stress. Such replication stress is a barrier to cancer.
And yet, how EBV-cancer cells overcome such stress at replication forks to successfully proliferate is not well
understood. In addressing this knowledge gap, we combined isolation of proteins on nascent DNA (iPOND) and
mass spectrometry to discover novel fork proteins. This revealed a critical role for ZC3H18 (or ZC3) as a
replication dependency factor that EBV upregulates to ensure host genome replication and lymphoma cell
proliferation; notably, ZC3 had not been previously linked to DNA replication. Indeed, EBV+ DLBCL from AIDS
patients have elevated ZC3 expression compared to EBV- lymphomas. An intrinsically disordered protein, ZC3
has the potential to concentrate a variety of proteins at replication forks. We find a direct interaction between
ZC3 and MCM7 (a core component of the replicative helicase complex), further pointing to ZC3’s influential role
in proliferation of EBV transformed cells. Importantly, ZC3’s partnership with other replication dependency factors
exposes EBV-lymphoma cells to synthetic lethality – such therapies exploit the property that cancer cells tolerate
perturbation of a single gene but succumb to co-disruption of multiple genetic events.
In this application, we will test the hypothesis that EBV modulates the DNA replication machinery, ensuring
proliferation of transformed cells in the face of replication stress and enhancing the potential for susceptibility to
synthetic lethality. We will perform the following aims using ex vivo models and translate our results to patient-
derived EBV+ AIDS lymphomas obtained from the AIDS and Cancer Specimen Resource (ACSR).
Aim 1. Investigate how novel dependency factors unmask synthetic lethal vulnerabilities in EBV-
transformed cells & Aim 2. Investigate mechanisms of ZC3 upregulation, replication machinery rewiring,
and contribution of replication dependency factors to EBV+ AIDS lymphomas.
These studies will identify mechanisms and generate new paradigms that reveal how an opportunistic virus
modulates the host replication machinery to maintain the transformed state. Our long-term goal is to identify
novel druggable targets that demonstrate synthetic lethality against EBV+ lymphomas in persons with HIV/AIDS.

Public health relevance
NARRATIVE / PUBLIC HEALTH STATEMENT Non-Hodgkin lymphomas remain a common cause of cancer-related death in HIV-infected individuals – highlighting the importance of additional factors such as the opportunistic cancer-causing Epstein-Barr virus (EBV). In this application, we address how EBV rewires cellular DNA replication to facilitate cancer cell proliferation instead of death. We expect our findings to reveal vulnerabilities that may be targeted via novel synthetic lethal approaches to treat EBV-driven HIV/AIDS-lymphomas.